Midwest DDRCC Alliance Conference (Hosted by the Mayo Clinic DDRCC)

PROJECT SUMMARY
The goal of this application is to obtain additional funds for the Midwest Digestive Disease Research Core
Centers (DDRCC) Alliance Conference to be held during the Fall of 2023. The Midwest DDRCC Alliance
(MDA) is comprised of 6 NIDDK-funded DDRCCs located in the Midwest: Case Western Reserve University,
Cincinnati Children's Hospital, Mayo Clinic, University of Chicago, University of Michigan, and Washington
University in St Louis. The Midwest DDRCC Alliance Conference (MDAC) was initiated in 2013 to promote the
career development of postdoctoral and junior faculty members and to provide a forum for cross-fertilization of
knowledge and research progress among the participating institutions. The conference’s scientific program is
comprised of junior faculty research projects that seek to advance the understanding of biological systems
influencing digestive health and disease. The requested funds will allow the conference to continue to provide
opportunities for junior investigators' career development, mentoring, and networking and to familiarize them
with core services and scientific and technology expertise available at the MDA partner sites. Finally, a major
component of this application is to promote careers of women and individuals from populations under-
represented in the scientific research enterprise as they seek to become investigators in digestive and liver
disease. We will feature successful women and investigators from diverse backgrounds to serve as role
models and mentors and to expand our community of researchers interested in digestive and liver disease.

Public health relevance
PROJECT NARRATIVE Digestive and liver diseases have a significant effect on public health and health care utilization costs. This application requests support for a conference that nurtures junior investigators, particularly women and individuals from populations under-represented, interested in digestive and liver disease research. Our goals are to provide additional mentoring support during a critical time in their career and to familiarize them with the scientific and technological expertise available at Midwest Digestive Disease Research Core Centers.